ADMINISTRATIVE CORE

Administrative Core ("AC") will be responsible for overall operations and management of the Center. Responsibilities will include organizing the bi-weekly Steering Committee meetings, the internal and external Advisory Board meetings, the management and disbursement of funds for the Workshops Symposia, and the short-term fellowships in the various categories. The Administrative Core will provide the office support for all of the activities of the Education and Outreach Core. This Core will interact with all other units in the Center to facilitate their activities, and will have a full-time Administrative Assistant and part-time financial manager (15%) and senior administrator (10%). The PI of the Core will be Ravi lyengar, who will devote 10% of his time.